Heparan Sulfate 3-O-Sulfation in Transcellular Propagation of Tauopathy in Alzheimer's Disease

Neurofibrillary tangles (NFT) is a pathological hallmark of Alzheimer’s disease (AD). NFT is composed of
aggregated tau protein and is correlated to cognitive decline in dementia progression. NFT spreads in the brain
in a prion-like manner, mediated by the interaction between tau and neuronal surface glycans. The long-term
goal is to study the structural details of tau-glycan interaction and to discover drugs to disrupt this interaction
for disease-modifying treatment of AD. In this proposal, we will study the tau-heparan sulfate interaction from
at the molecular (aim 1), the cellular (aim 2), and organismal level and carry out drug discovery (aim 3).

Public health relevance
Alzheimer’s disease (AD) is one of the most serious challenges to public health in US. Tau protein aggregates to form neurofibrillary tangle (NFT), a pathological hallmark of AD. NFT spreads transcellularly via the interaction between tau and cell surface glycans. We will study the structural details of tau-glycan interaction for structure-based drug discovery. The detailed data on the interaction between tau and glycan will provide tremendous insight into molecular mechanism of tau pathology and AD pathogenesis, and point to new directions in AD drug discovery.